A Translatable Form of Hypoxia Therapy for Impaired Mitochondrial Proteostasis

PROJECT ABSTRACT
Our previous work demonstrated that hypoxic breathing, simulating high-altitude living, can prevent and reverse
neurological damage in a mouse model of mitochondrial electron transport chain (ETC) deficiency caused by
mutations in a key complex 1 subunit. This research revealed that chronic hypoxia significantly extends lifespan
and rescues biomarkers, behavior, and neuropathology. Building on these findings, a Phase 1 clinical trial
exposing healthy volunteers to controlled hypoxia was performed.
To expand the understanding of hypoxia therapy's broader applicability, we are now testing the ability of low
oxygen to rescue additional mitochondrial diseases caused by mutations in the mitochondrial proteostasis
system. Furthermore, we propose investigating two potential mechanisms of hypoxia-mediated rescue: (1)
activation of the hypoxia-inducible factor (HIF) transcriptional response to promote metabolic adaptations and
(2) stabilization of iron-sulfur (Fe-S) cluster-containing protein complexes affected by ETC dysfunction.
By elucidating these mechanisms, this research will provide critical insights into optimizing hypoxia-based
therapies for mitochondrial diseases and inform treatment strategies for broader clinical applications.

Public health relevance
PROJECT NARRATIVE We recently showed that hypoxia reverses disease in a mouse model of mitochondrial electron transport chain complex 1 deficiency. We now propose comprehensively and mechanistically studying the ability of hypoxia to rescue a mouse model of impaired mitochondrial proteostasis.